Patterning acentrosomal microtubule arrays

Abstract
The microtubule cytoskeleton supports cell-division, cellular morphology and intracellular cargo
transport. While the centrosome is a major site of microtubule nucleation in dividing cells, many differentiated
cells harbor acentrosomal microtubule arrays. Prominent examples include germline cells, plant epidermis,
epithelia and neurons. To understand cellular differentiation, it is crucial to learn how acentrosomal array
architecture is set up to achieve a specific pattern of polymer numbers, length and distribution that would
support specialized cellular functions.
My laboratory studies the patterning of acentrosomal microtubules and its effect on cargo transport in
C. elegans. We developed imaging tools and algorithms that allow an unprecedented level of analysis of
microtubule organization in vivo and are compatible with live-imaging of cargo transport. We conducted
unbiased screens to uncover novel microtubule regulators and are using genetics, imaging, and biochemical
methods to understand their mechanisms. In parallel, we are investigating the biological significance of
microtubule array patterns by examining the effects of these regulators on long-range intracellular transport.
This proposal details our recent progress, including the finding of dynein regulation by an immotile
kinesin at the microtubule minus-end, the identification of a protein that promotes nucleation with -tubulin, and
uncovering a mechano-transduction pathway that adjusts microtubule positioning in response to stretch. For
the next period we propose work that follows up on microtubule nucleation and minus-end protection, the
distribution of microtubule polymers, and the regulation of cargo transport by MAPs. Given the fundamental
roles of microtubules in differentiated cells, we expect this work to provide meaningful insights in the broad
fields of cellular differentiation, cytoskeleton and transport. The involvement of cytoskeletal defects in
numerous disorders suggests that in the long-term, our studies will help to shed light on mechanisms of cellular
dysfunction that occurs during disease.

Public health relevance
Project Narrative Microtubules are polymers used by differentiated cells as tracks on which to transport proteins and organelles. This study examines how cells regulate their microtubule cytoskeleton and its function. Since microtubules are involved in a range of diseases, increasing our knowledge about their function could, in the long-term, contribute to improving human health.